PRODUCTION AND DISTRIBUTION OF FILARIAL RESEARCH REAGENTS DATA

This contract produces and supplies essential reagents to U.S. based research laboratories conducting critical research to develop medical countermeasures against lymphatic filariasis.